Built environment approaches to physical activity: Testing community-driven implementation strategies

PROJECT SUMMARY/ABSTRACT
Built environment approaches make it safer and easier for people across the life span to walk, bicycle, or
wheelchair roll, and mitigate barriers to physical activity by making the healthy choice the default choice. The
National Cooperative Extension system—which serves every state and territory by bringing land-grant
university resources to community members—is poised to implement built environment approaches. However,
barriers exist, and relevant implementation strategies are needed to improve adoption rates. There is a dearth
of research on implementation strategies (methods or techniques to improve uptake of evidence-based
interventions) for community settings, and little is known about effective strategies for integration of built
environment approaches. There is a critical need to develop and test evidence-based, community-driven
implementation strategies to build practice-level capacity to select, adapt, and implement built environment
approaches to address locally identified needs. With this support, Extension can integrate built environment
approaches into their work and improve the health of the millions of Americans they serve. The long-term goal
of this work is to establish an evidence base of tested implementation strategies to bridge research to practice
in Extension and ultimately improve population physical activity levels, thereby reducing cancer risk. Montana
has been selected for initial pilot testing due to a strong collaborative history and presence of an integrated
research-practice partnership (IRPP). The overall goal of this proposed project is to establish implementation
strategies to increase the uptake of built environment approaches in Montana. The rationale that underlies the
proposed research is that without community-driven, tailored implementation strategies, community
organizations will continue to struggle with implementing built environment approaches. The specific aims are
to 1) systematically select and tailor implementation strategies to increase the uptake of built environment
approaches in Extension and 2) pilot test the tailored implementation strategies through an iterative, mixed-
methods approach. The first aim will employ an IRPP process to engage Extension professionals in selecting
and tailoring implementation strategies through a series of collaborative decision-making sessions. The second
aim will use the expanded RE-AIM (reach, effectiveness, adoption, implementation, maintenance) framework
(integrating the Implementation Outcomes Framework) to assess 1) acceptability, appropriateness, and
feasibility of built environment approaches (predictors of adoption), 2) Extension Agents’ adoption of built
environment approaches (primary outcome), and 3) acceptability, appropriateness, feasibility, reach, and cost
of implementation strategies to guide final revisions. The research proposed in this application is innovative
because it incorporates key community partners to tailor and test implementation strategies rather than
providing top-down strategies that do not address contextual factors. This work is significant as a first step to
begin compiling evidence-based, community-driven implementation strategies to address relevant barriers.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as more than 80% of Americans do not meet physical activity levels associated with reduced cancer risk. Built environment approaches are recommended to enhance population physical activity levels, but are difficult to implement by community organizations without tailored support. The proposed study will leverage an established partnership with Montana State University to select and evaluate community-driven implementation strategies to improve the uptake of built environment approaches in the Cooperative Extension System.